Targeted Neural Text Summarization of Electronic Medical Records to Improve Imaging Diagnostics

Project Summary
Targeted Neural Text Summarization of Electronic Medical Records to Improve Imaging
Diagnosis
Electronic health records (EHRs) contain a wealth of patient information that might inform diagnostic
and therapeutic decision-making. However, much of this information is unstructured (i.e., free-text). This
makes it difficult to find the few relevant notes that might inform a given decision amongst lengthy
patient records, in turn rendering key information buried within EHR practically inaccessible to domain
experts operating under time constraints. Consequently, clinical decisions are often made without the
benefit of all available data. We propose to design, train, and deploy novel natural language processing
(NLP) models that provide extractive summaries of the free-text data within EHR conditioned on
particular queries; the intent is for such models to aid diagnosis and decision-making. We also propose to
use these models to try and counteract the cognitive biases that domain experts bring to clinical practice.
We focus specifically on the important and illustrative area of radiology, although the approach will
generalize to other specialties. Radiologists performing imaging diagnosis do not have adequate time to
carefully read through patient histories stored within EHR; they must instead make do with limited
background information when interpreting imaging. We will build on our preliminary on models that
summarize textual evidence extracted from EHR that might support particular hypothesized diagnoses.
We envision an interactive system in which this model is used by the radiologist to surface textual
evidence that supports different potential conditions that might be suggested by the imaging.
Radiologists (and other domain experts) rely on heuristics — type 1 thinking — when making decisions
under time constraints. This results in various cognitive biases influencing diagnoses, and these have
been shown to be the source of a significant fraction of diagnostic errors in radiology. We propose a novel
secondary use of the NLP models to be developed for this project as a means of counteracting these
cognitive biases. Specifically, once the radiologist has indicated an initial potential diagnosis via a natural
language query, we will automatically present a few alternative plausible diagnosis and summaries of the
extracted evidence supporting these (alongside the summary of evidence relevant to the initial query).
These alternative diagnoses will be gleaned from gamuts or published lists of differential diagnoses, and
we will re-rank them in order of their predicted probability for the current patient according a trained
machine learning model. We will evaluate the proposed models in practice at Brigham and Women's
Hospital, and assess the degree to which integrating automatically generated summaries actually affects
clinical decision-making at point of care.

Public health relevance
Project Narrative Targeted Neural Text Summarization of Electronic Medical Records to Improve Imaging Diagnosis Relevant information from a patient's medical history is essential to allowing specialists (such as radiologists) come to accurate diagnoses; unfortunately, this key information is often buried in the unstructured clinical notes within patient Electronic Health Records (EHRs), making it difficult to find and draw upon to inform diagnosis. We propose to design and evaluate novel Natural Language Processing methods that provide focussed extractive summaries of the text within patient EHR to aid radiologists performing imaging diagnosis and counteract the cognitive biases of radiologists (while our focus is on radiology, the proposed approach will generalize to other specialties, providing a potentially novel and impactful means for domain experts to better harness EHR to improve care). We will assess whether and how these automatically generated summaries affect diagnosis in a pilot user study, providing insights into how (interactive) machine learning models might influence clinical practice.